Optimizing Benefits While Reducing Risks of Iron in Malaria-Endemic Areas

ABSTRACT
Ensuring sufficient iron for the brain development of tens of millions of children living in malaria-endemic areas
while also protecting them from infection has been an unachieved public health goal for more than a decade.
Iron supplementation in these global areas is linked with increased risks of malaria and other infections. One
solution to safely and effectively treat coexisting malaria and iron deficiency is to stagger the interventions,
treating malaria first and delaying the start of iron until 28 days later. Preliminary data from our recent R03 pilot
study demonstrate that this strategy causes the hepatic protein hepcidin to decline, allowing oral iron to be
better absorbed and incorporated into hemoglobin, and also reduces the risk of infections in the short-term.11
The objective of this application is to conduct a placebo-controlled, randomized clinical trial to determine
whether iron treatment begun concurrently with vs. 28 days after antimalarial treatment in Ugandan children 6-
48 months with malaria and iron deficiency results in better long-term iron status, fewer infections, and better
neurobehavioral development after 12 months. The central hypothesis is that better iron incorporation and
lower incidence of infectious illness observed with 28-day delayed iron in the R03 study with only 8 weeks
follow-up will translate into sustained improvements iron status, lowered risk of infection, and improved
cognitive and behavioral outcomes. The rationale of this study is that staggering antimalarial treatment and
iron therapy protects against immediate morbidity while also optimizing long-term neurobehavioral
development. Guided by strong preliminary data, the specific aims are: 1) Establish the effect of immediate vs.
delayed iron treatment on long-term iron status; 2) Determine the effect of delayed iron treatment on the
incidence of infectious illness; and 3) Establish the effect of delayed iron treatment on neurobehavioral
development. Analysis of the gut microbiome in the delayed and immediate iron group will provide insight into
potential mechanisms of any observed differences in morbidity between the groups. The translational research
team is uniquely suited to assess neurobehavioral outcomes, a critical, but typically unmeasured functional
outcome of a successful management approach for iron deficiency and infection. Establishment of methods to
safely and effectively ensure brain iron while also protecting from infection will permit attainment of full
cognitive and behavioral development for tens of millions of children worldwide suffering from iron deficiency
and malaria.

Public health relevance
Public Health Relevance Iron deficiency and malaria coexist in sub-Saharan Africa and frequently lead to anemia, cognitive impairment, and mortality among children < 5 y. Expanding upon a pilot study funded through an R03 mechanism, the present application is placebo-controlled, randomized controlled trial testing the effect of iron therapy begun concurrently with antimalarial treatment or 28 days after antimalarial treatment on iron status, incidence of infectious illnesses, and neurobehavioral development after 12 months. The results of this study will establish the optimum sequencing of iron and antimalarial treatment for managing concurrent iron deficiency and malaria, thus guiding future iron intervention programs in malaria-endemic and high-infection settings.